CELLULAR AND MOLECULAR GEROSCIENCE CoBRE

ABSTRACT
This project aims to advance aging research by developing a biomarker for aging using a
model based upon the epigenetic clock, a machine learning model that predicts age from DNA
methylation changes in any human tissue. We propose to test these clocks’ association to
cognitive and vascular pathologies, as well as to generate new clocks designed to predict age-
related dysfunction. We propose to evaluate the performance of epigenetic clocks in clinical
samples by correlating cognitive function and vascular-cognitive impairment measures with DNA
methylation data. Our goal is to determine if epigenetic clocks can serve as an aging biomarker
using accessible tissue (blood) to predict age-related vascular and cognitive dysfunction. Aim 1
of the project will determine the ability of epigenetic clocks to predict age-associated vascular and
cognitive impairment from blood samples. We will test the association between Horvath, Levine,
and our own epigenetic clocks’ “age acceleration” and functional data on cognition and brain
vascular health from human samples. We will generate methylation data from previously collected
white blood cells, which will be paired with cognitive assessment using the Cambridge
Neuropsychological Test Automated Battery (CANTAB) of cognitive tests, cerebrovascular health
using transcranial doppler (TCD), functional near-infrared spectroscopy (fNIRS), dynamic retinal
vessel analysis, and peripheral vascular health using the flow mediated dilation approach in large
(ultrasonography) and small vessels (laser speckle contrast imaging). We hypothesize that age
acceleration should be negatively correlated with cognitive and vascular function both in central
circulation and in the periphery. These analyses will provide evidence critical to determining if
epigenetic clocks can be a clinically relevant biomarker for aging in the brain. In the Aim 2, we will
design new epigenetic clocks to predict vascular and cognitive impairment and evaluate their
association to AD and cognitive impairment in a meta-analysis of public data. Using the same
epigenetic data generated in aim 1, we will train new epigenetic clocks that predict functional
impairment instead of chronological age. We hypothesize that epigenetic clocks trained to predict
vascular and cognitive dysfunction will also be able to predict age-related disease status.

Public health relevance
Project Narrative Lifespan studies in animal models, often involving lifetime treatment, are considered the gold standard for assessing these therapies, however, the lengthy duration of these studies makes it challenging to apply their findings to human clinical trials. Several epigenetic clocks, a machine learning models using DNA methylation were proposed to predict age and mortality rate, however, these clocks often show weak correlations with clinically relevant variables. This supplemental team science proposal will combine bioinformatics prediction capability to create a functional epigenetic clock with in-lab experimental validation of its utility to predict agerelated changes in human brain and cerebrovascular function.